Biomedical Engineering Core

Abstract
Circulating markers found in accessible samples (blood, saliva, urine, etc.) represent an exciting biomarker
class due to the minimally invasive nature of securing them. Potentially, these circulating markers can enable
studies directed toward understanding the pathophysiology of a disease and translating those discoveries to
the bedside for managing a host of human diseases by matching the molecular characteristics of the disease
to proper treatment regimens (i.e., precision medicine). The attractive nature of circulating markers (i.e., liquid
biopsy markers) is the plethora of marker types found in the sample such as biological cells, cell-free
molecules (proteins and cell-free DNA) and extracellular vesicles (nanometer assemblies such as exosomes).
Unfortunately, basic studies and clinical translation of these liquid biopsy markers has been challenging due to
the lack of efficient platforms for their isolation that can also accommodate downstream molecular
characterization of the circulating marker cargo. KIPM will generate the Biomedical Engineering Core that will
provide to COBRE investigators transformative tools, including hardware and the associated assays, that can
be programmed for the project at hand and provide to investigators high quality circulating markers to serve as
inputs for a variety of molecular characterization assays (DNA/RNA Next Generation Sequencing, proteomics,
immunoassays, mutation detection, liquid chromatography/mass spectrometry, and many others). The
hardware tools are lab-on-a-chip or microfluidic platforms that have been optimized for the isolation of
circulating markers and clinically validated in a variety of application areas. The microfluidic tools also have
validated assays and an automated workflow that has been developed by members of the BME Core. These
tools have noteworthy performance metrics compared to commercially available products directed for the
isolation of circulating markers. The microfluidics are produced in a high scale production mode at low cost
because they are made from plastics and formed into the appropriate structures using injection molding, an
established production pipeline for producing CDs, DVDs and Blu-Ray discs. Using these tool sets, the BME
Core will create a laboratory that can immediately service COBRE investigators on their precision medicine
based projects. Due to the unique capabilities of the tools employed by the BME Core, the data sets generated
by the KIPM investigators and the unique tools to acquire these data sets will improve their competitiveness in
seeking federally-funded support of their projects. For COBRE projects that cannot be effectively serviced by
the Core’s existing tools, the Core will work with the project PI to design new tools to accommodate their
project that will also add new process capabilities to the BME Core. The BME Core has assay design
capabilities and prototyping tools to support this activity.